Efficacy and Mechanisms of Combined Aerobic Exercise and Cognitive Training in MCI_The ACT Trial COVID Admin Sup

Brief Summary of Protocol (5,000 characters max)
The purpose of this single-blinded, 2×2 factorial Phase II randomized controlled trial (RCT) is to test the
efficacy and additive/synergistic effects of a 6-month combined cycling and speed of processing (SOP) training
intervention on cognition and relevant mechanisms (aerobic fitness, AD signature cortical thickness, and
functional connectivity in the default mode network [DMN]) in older adults with amnestic MCI (aMCI). Our
preliminary studies have shown that enhanced aerobic fitness is associated with better cognition and resting-
state functional connectivity in the DMN in AD, and ~20 hours of SOP training improves executive function and
maintains functional connectivity in the DMN in aMCI. This RCT will randomize 128 participants equally to 4
arms: ACT, cycling only, SOP training only, or attention control for 6 months, and then follow them for another
12 months. Cognition and aerobic fitness will be assessed at baseline, 3, 6, 12, and 18 months; AD signature
cortical thickness and functional connectivity in the DMN at baseline, 6, 12, and 18 months; AD conversion at
3, 6, 12, and 18 months. The specific aims are to: Aim I. Determine the efficacy and additive/synergistic effects
of ACT on cognition over 6 months. H1: ACT will have the greatest effects on executive function and episodic
memory compared with other groups. Aim II. Examine the underlying mechanisms of ACT over 6 months. H2a:
ACT will have the greatest effects on AD signature cortical thickness, functional connectivity in the DMN, and
aerobic fitness compared with other groups. H2b: Changes in the mechanistic measures are related to
cognitive changes. H2c: Changes in AD signature cortical thickness and DMN mediate aerobic fitness' effects
on cognition. Aim III (exploratory). Calculate the long-term effect sizes of ACT on cognition and clinical and
pathological AD conversion to inform future Phase III RCTs. Analysis will use intention-to-treat and linear
mixed-effect modeling. This trial will be the first to test the synergistic effects on cognition and mechanisms
(relevant to AD-associated neurodegeneration) of a uniquely conceptualized and rigorously designed ACT in
older adults with aMCI. It will advance AD prevention research by providing precise effect-size estimates of the
ACT intervention. Our long-term goal is to delay AD onset and slow AD progression.

Public health relevance
PROJECT NARRATIVE Preventing Alzheimer’s disease (AD) is the most important approach to tackle the AD epidemic that affects 5.4 million Americans and 15.9 million family members, because no drugs have yet been identified that can prevent, treat, or even slow down the progression of AD. This study will examine a program combining aerobic exercise (cycling) and a specific type of cognitive training (speed of processing training) for its ability to improve reasoning and memory, as well as to improve brain structure and function potentially related to AD- associated nervous system deterioration, in older adults with amnestic mild cognitive impairment (which is known to be a precursor to AD). If this program is found to be effective, such a program could be investigated further to assess its promise for preventing or delaying the onset of AD.